Origins of DNA damage driving pathology in human neurodegeneration

Loss or mutations in both alleles of the gene encoding ataxia-telangiectasia mutated (ATM)
kinase results in early-onset cerebellar ataxia and progressive neurodegeneration in humans.
Mechanistic explanations for this phenotype, as well as for the related A-T like Disorder (ATLD)
caused by rare mutations in the MRE11 gene, have been elusive despite years of work on these
enzymes. ATM is a master regulator of the DNA damage response, controlling checkpoint
responses and survival of DNA damage in all cell types. We have previously characterized the
ATM protein kinase in vitro, using purified proteins to determine that ATM is activated at sites of
DNA double-strand breaks and can also be activated independently of breaks by oxidative
stress. In recent work we found that loss of ATM kinase activity results in the formation of
protein aggregates—detergent-resistant insoluble forms of proteins—enriched for polypeptides
with intrinsically disordered domains. These aggregates form in response to hyperactivation of
poly-ADP-ribose polymerases (PARPs) that are activated at sites of transcriptional stress.
Analysis of 21 patient cerebellum tissue samples also showed massive levels of aggregates as
well as hyperPARylation in comparison to controls, consistent with these observations. Based
on this evidence we propose that protein aggregation may play a causal role in the
neurodegeneration that occurs in this disorder, similar to other forms of cerebellar ataxia and to
more common late-onset neurodegeneration in the human population. Here we propose to
characterize the origin of single-strand DNA breaks that occur in the absence of ATM function to
test the hypothesis that the combined effects of oxidative stress and transcription-dependent
damage is responsible for the strand breaks and resulting protein aggregates that are observed
with loss of ATM in human neurons. We will also characterize the locations and requirements
for strand breaks seen in neurons expressing ATLD alleles of MRE11 and test the hypothesis
that the Mre11-Rad50-Nbs1 (MRN) complex promotes single-strand break repair using in vitro
biochemistry with purified proteins. These experiments will test novel hypotheses about the
functions of ATM and MRN in neurons and the origins of DNA damage during cerebellar
neurodegeneration.

Public health relevance
There are no known cures for neurodegeneration—the progressive loss of neurons that can occur sporadically in the human population with age and also in patients with specific genetic mutations. Here we use early-onset, familial cerebellar neurodegeneration as a model to understand the molecular events that occur early in the progression of disease. We hypothesize that unrepaired breaks in DNA are a key component of this progression and use human neurons in culture as well as biochemistry-based approaches to characterize the origin and consequences of this DNA damage.